IGF::OT::IGF Task Order #1 "Kickoff Meeting with NCI Staff" POP: 9/18/17-10/17/17

The purpose of this Task Order is to explain the tasks and the goals associated with the Indefinite Delivery/Indefinite Quantity (IDIQ) contract for the “Synthesis of Non-GMP Small Molecules”, including a review of expectations.